Targeting the RNA helicase DDX6 in acute myeloid leukemia

PROJECT SUMMARY
Acute myeloid leukemia (AML) is an aggressive blood cancer characterized by the accumulation of abnormal
myeloid progenitors arrested in differentiation. It is the most common form of leukemia among adults and the
second most common among children. Despite considerable advances in our understanding of this disease,
prognosis for AML patients remains dismal, with five-year survival rates languishing at <30% despite the use of
intensive chemotherapy. Thus, there is a compelling need to identify novel molecular vulnerabilities of AML to
help guide the development of more effective targeted therapies. The RNA helicase DDX6 emerged as a
prominent hit in our CRISPR dropout screens aimed at identifying specific AML dependencies. DDX6 represses
the translation of target mRNAs by using its ATP-dependent helicase activity to sequester them in P-bodies,
cytoplasmic ribonucleoprotein granules. Our preliminary data indicate that AML cells overexpress DDX6 and
harbor more P-bodies compared to normal hematopoietic progenitors. We find that loss of DDX6, triggering P-
body dissolution, attenuates self-renewal of AML cells and promotes their differentiation in vitro but has little
effect on normal hematopoietic progenitors. Congruently, we also find that loss of DDX6 abrogates the expansion
of AML cells in vivo. By purifying intact P-bodies from AML cells, we found enrichment of potent tumor
suppressors (e.g., KDM5B, TLE4, TRAF6) among the mRNAs sequestered by DDX6 in P-bodies. Together,
these data lead us to hypothesize that DDX6 is a specific AML dependency that sustains AML by
sequestering and translationally repressing mRNAs encoding tumor suppressors. We will test this
hypothesis through two Specific Aims. In Aim 1, we will define the functional requirement for DDX6 in AML using
novel mouse models. We expect that Ddx6 loss or mutation of its helicase activity will prevent or delay AML
onset in vivo. Conversely, we expect that Ddx6 overexpression will accelerate AML onset in vivo. In Aim 2, we
will elucidate the molecular mechanisms by which DDX6 sustains AML. We predict that we will find mRNAs
encoding tumor suppressors to be enriched in the P-bodies of AML cells and translationally repressed. We
anticipate that loss of DDX6 will de-repress these mRNAs and promote their translation and protein expression.
Collectively, these experiments will unveil the RNA helicase DDX6 as a potential therapeutic target in AML by
establishing it as a specific AML dependency and deciphering the mechanistic basis for this dependency. This
study will also provide the first evidence of an oncogenic role for P-bodies in the context of hematological
malignancies and may uncover novel tumor suppressors among DDX6 targets that can potentially be exploited
against AML.

Public health relevance
PROJECT NARRATIVE Acute myeloid leukemia (AML) remains a devastating disease with poor prognosis. This project will establish the RNA helicase DDX6 as a novel potential therapeutic target in AML by establishing it as a specific AML dependency and providing mechanistic insights into the molecular mechanisms underlying this dependency. We expect that the results from our studies will guide the development of targeted, precision therapies against AML.